Role of the Parkinson's susceptibility gene LRRK2 in NFAT-mediated malignant mesothelioma tumorigenesis

PROJECT SUMMARY/ABSTRACT
Malignant Mesothelioma (MM), particularly the pleural form of this disease, is a treatment-resistant, rapidly fatal
cancer of serosal cells lining the internal body cavities. Exposure to asbestos is causally associated with the
development of MM, and asbestos-induced inflammation is a major contributing factor in this process. In some
families, heterozygous germline mutations in certain cancer-related genes, especially BAP1, predispose to MM,
and mouse models carrying Bap1 mutations have enhanced susceptibility to the carcinogenic effects of
asbestos. Moreover, somatic BAP1 mutations/deletions occur in 50-60% of human MM specimens. Our recent
whole genome sequencing study of MM patients with a family history of cancer uncovered two families with
germline mutations in the Parkinson’s susceptibility gene LRRK2, including a truncating mutation in one family
in which 6 siblings developed pleural MM. We later found loss of LRRK2 protein expression in 61% of primary
pleural MPMs and MPM cell lines from unrelated individuals. LRRK2 has been linked with various cellular
pathways, one of which (NFAT signaling) is implicated in inflammation/immune response and carcinogenesis.
Our broad, long-term objective is to determine if LRRK2 loss contributes to MM formation and progression, in
part, by dysregulating NFAT, and whether targeting this pathway would have significant therapeutic benefits. In
this project, we propose to test whether LRRK2-mediated interactions with NFAT play a key role in asbestos-
induced inflammation and MM tumorigenesis. Our hypothesis is that LRRK2 acts as a tumor suppressor gene
in MM, that loss of LRRK2 expression contributes significantly to MM pathogenesis, and that future therapeutic
approaches exploiting functional attributes associated with LRRK2 loss can lead to improved clinical outcomes
in this disease. Overall, this project seeks to elucidate mechanisms by which inactivation of LRRK2 contributes
to asbestos carcinogenesis and MM development using a combination of cell biological and in vivo approaches.
We propose the following Specific Aims: 1) Does LRRK2 loss promote asbestos-induced tumorigenesis? We
will determine if Lrrk2-deficient mice are predisposed to the carcinogenic effects of asbestos, as demonstrated
by accelerated asbestos-induced MM development compared to wild-type (WT) littermates. Additionally, we will
ascertain if the immune tumor microenvironment differs between MMs from Lrrk2-deficient mice and MMs from
WT mice, and if a comparable difference occurs in human MPM. 2) Does LRRK2 loss enhance NFAT-driven
inflammatory signaling? Asbestos is thought to contribute to MPM development by inducing inflammation, and
we propose to test whether LRRK2 suppresses such inflammation by dampening activity of the transcription
factor NFAT. LRRK2 has been shown to bind to the NRON complex, blocking transport of NFAT from the cytosol
to the nucleus when cells are in a resting state. Loss of LRRK2 will therefore be expected to cause NFAT to be
translocated to the nucleus to mediate transcription. Here we will test if this mechanism may explain how LRRK2
loss may potentiate asbestos-induced inflammation and MM tumorigenesis.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH DNA variants leading to enhanced activity of the LRRK2 gene product are associated with an increased risk of Parkinson's disease, whereas decreased activity of LRRK2 due to mutation or loss of expression recently has been reported in breast and lung cancers as well as in mesothelioma, a treatment resistant-tumor causally linked to asbestos-induced inflammation and tissue damage. LRRK2 plays a role in several cellular signaling pathways, one of which (NFAT signaling) is implicated in both inflammation/immune response and the process by which normal cells are transformed into cancer cells. In this project, we will use a combination of cell biological and mouse model approaches to determine if LRRK2-mediated interactions with NFAT play significant roles in asbestos-induced inflammation, mesothelioma formation, and the environment surrounding the tumor, with the long-term goal of ascertaining if LRRK2 can serve as a useful biomarker for stratifying patients for precision therapies.